The UC Irvine Center for Neural Circuit Mapping training program in Alzheimer's disease research

Project Summary / Abstract
Dementias from Alzheimer’s disease (AD) and age-related cognitive impairments are a major health and socio-
economic concern in the US and worldwide. AD remains resistant to treatment based on earlier research efforts.
Approximately 20% of the US population will be 65 or older by year 2030; roughly 8 million of these individuals
are expected to suffer from AD. The neural circuit aspects of AD are an emerging new research area with
tremendous potential for growth and progress. The UC Irvine Center for Neural Circuit Mapping (CNCM)
research program has quickly established strong federal funding that supports our transformational projects with
significant clinical translational potential. The ongoing acceleration of our understanding of the nervous system
will drive the development of new therapeutic strategies to treat AD and other brain diseases over the next
decades. Our new CNCM research program has unified multidisciplinary investigators from multiple academic
units across UC Irvine including the Schools of Medicine, Biological Sciences, Pharmacy and Pharmaceutical
Sciences, Engineering, and Information and Computer Science. Our T32 program is designed to train the next
generation of researchers focused on neural circuit studies of brain disorders including AD and related
dementias. The proposed training program will be administered by the CNCM and will be supported by CNCM
investigators who have fostered a highly collaborative environment exemplifying interdisciplinary team-based
research. Our exciting and diverse group of faculty members will mentor and support predoctoral and
postdoctoral trainees in neural circuit studies using a range of interdisciplinary approaches combining analysis
of mouse genetic models and post-mortem human brain tissues with state-of-the-art technologies that include
viral genetic mapping, in vivo neural ensemble recording/imaging, single-cell genomics, engineering and
computational modeling. Our faculty mentors and trainees will expand our mechanistic understanding of
Alzheimer’s disease and other disorders and develop tools that enable early detection and diagnosis. Our
training plan is well defined; trainees are required to take courses and seminars related to cutting-edge
neuroscience and AD research with a neural circuit focus. We anticipate four trainees per year (2 pre- and 2
postdocs) whose training will continue until they complete their respective programs. Critically, we will teach our
trainees to develop their own unique tools and methodologies to address scientific questions that others cannot.
We include training in rigor and reproducibility, statistics and data analysis training, and professional
development. The expected outcome of our T32 program is to establish a successful training pipeline to prepare
trainees with career-long experimental and quantitative skills as future research leaders who will focus on neural
circuit analysis of Alzheimer’s disease and related dementias.

Public health relevance
Project Narrative The UC Irvine Center for Neural Circuit Mapping T32 Training Program will prepare the next generation of basic science researchers with an emphasis on neural circuit analysis of Alzheimer’s disease and related dementias. Our program emphasizes training young scientists with the cutting-edge, collaborative and interdisciplinary research that will be required to identify new therapeutic targets and to develop innovative tools for treating Alzheimer disease and related dementias.